Advancing Alzheimer's Diagnosis: MRI-Based Predictive Modeling of Alzheimer’s Disease Molecular Subtypes

PROJECT SUMMARY
Alzheimer's Disease (AD) is a progressive neurodegenerative disorder that impacts cognition and
memory, imposing a substantial burden on the aging population. While individuals generally need to display core
clinical and biological features to meet diagnostic criteria for AD, there is substantial variability among patients
regarding onset and the course of the disease. This poses significant challenges to early diagnosis of AD and
impedes the development of effective therapeutic strategies. Molecular subtyping of AD is of high importance
due to its potential to identify disease mechanisms and new therapeutic targets. Recent studies have uncovered
evidence indicating that molecular subgroups of AD display distinct disease characteristics aligning with key
clinical features. The identification of distinct AD subtypes has spurred research regarding their potential to be
identified using non-invasive neuroimaging techniques, which holds promise for early detection. However,
progress towards this overarching goal has been impeded by studies lacking comprehensive data collected from
the same individuals. The goal of this proposal is to enhance our understanding of the biological signatures that
distinguish subgroups of patients with AD. We will use state-of-the-art computational approaches to jointly
analyze multiple levels of data collected from the same individuals, encompassing a genetic, epigenetic, and
neuroimaging information, constituting an unprecedented cohort in which to investigate AD subtypes. The
proposed investigation will address the following gaps in the current scientific knowledge:
1) We will determine whether AD subtypes can be identified solely using neuroimaging-derived features.
To address this question, we will use using state-of-the-art machine learning algorithms to predict molecular
subtype of AD from magnetic resonance imaging (MRI)-derived phenotypes.
2) AD is a multifaceted disorder in which epigenetic regulatory mechanisms play a crucial role. However,
prior studies on AD subtypes demonstrated limited or no integration of epigenetic information, thereby restricting
knowledge of variability between AD subtypes. To address this critical knowledge gap, we will integrate
epigenetic profiles previously associated with AD, encompassing expression levels of small non-coding RNAs
(miRNAs) and DNA methylation (DNAm) markers, to determine their contribution to AD subtypes. This multi-
omic approach has the potential to uncover new molecular signatures of distinct AD subgroups.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD), the most common form of dementia, is diagnosable based on a combination of clinical and biological indicators that generally exhibit consistency across patients, such as cognitive decline and memory impairment; however, substantial variability in the onset, progression, and manifestation of the disease among individuals poses significant challenges for early detection and management of AD. The objective of this proposal is to establish a computational model that can accurately identify distinct subgroups among AD patients based on gene activity patterns in the brain, all achieved non-invasively by neuroimaging techniques. Successful completion of this project will help reveal genetic pathways in the brain associated with the progression of AD, paving the way to identify new treatment targets and prevention strategies for this debilitating disease.